CORE B MICROIMAGING CORE

The Microimaqinq Core provides training and maintains the many compound and stereo microscopes required for the proposed projects. The Microimaging Core also provides several confocal microscopes, a spinning disk microscope, a custom built two-photon laser scanning microscope and a one-of-a-kind, custom light-sheet microscope for use of the Program.

Public health relevance
The aims of this Program Project Grant are to understand the developmental basis of phenotypic variation in three human diseases, Fraser syndrome. Usher syndrome and Hirschsprung disease. The four Core Units ~ Administration, Microimaging, Technical Support and Zebrafish Facility ~ provide the administrative and technical support required to accomplish the Aims of the Component Projects within this Program Project Grant.